Assessment of Achilles Tendon Injury in Adolescents

PROJECT SUMMARY/ABSTRACT
The incidence of Achilles tendon injury in youth sports has increased, yet Achilles tendon pathology in
adolescents has been poorly investigated. While the overuse injury of Achilles tendinopathy is clinically
diagnosed by pain with loading and loss of function in adults, the same symptoms in adolescents are instead
considered a growth plate disorder called calcaneal apophysitis. Calcaneal apophysitis and Achilles
tendinopathy may onset at different times during musculoskeletal growth in adolescents who consistently
overload their tendons. However, the involvement of Achilles tendon pathology amongst adolescents with
general heel pain is unknown. Further, the etiology of Achilles tendon injury has yet to be determined in the
adolescent population. It is speculated that an overdevelopment of triceps surae muscle alters Achilles tendon
structure (i.e., morphology and mechanical properties), resulting in heel pain during loading and loss of
function. With no clear clinical diagnostic delineation between apophysitis and tendinopathy for patients under
18 years old with heel pain, overlooking Achilles tendon pathology may result from an assumed diagnosis of
calcaneal apophysitis. Misdiagnosis and subsequent misaligned treatment of Achilles tendon injury in
adolescents can reduce quality of life and may impede the development of a physically active lifestyle into
adulthood. The growing incidence rates of lower limb tendinopathies in adolescence, and premature retirement
from youth sports due to debilitating injury, stress the need for adequate understanding of Achilles tendon
injury. Yet, Achilles tendon pathology research is disproportionately focused on the adult population, potentially
leaving the pediatric population at risk of long-term health issues.
The objective of this proposal is to investigate the effect of heel pain on adolescent Achilles tendon
health and lower limb biomechanics. Specifically, this study will evaluate Achilles tendon symptoms and
lower limb impairments (Aim 1), Achilles tendon structure and triceps surae muscle strength alterations (Aim
2), and Achilles tendon loading profiles (Aim 3) of adolescents with complaints of heel pain compared to
healthy adolescents. This work will contribute valuable evidence for establishing the pathoetiology of
adolescent heel pain, which is necessary to properly diagnosis and treat adolescents with heel pain so they
can maintain physically active lifestyles into adulthood. The long-term goal of this fellowship applicant is to
investigate mechanisms of musculoskeletal injury and improve clinical rehabilitation. The interdisciplinary
training this applicant will receive from expert biomedical researchers and clinical collaborators at the
University of Delaware during the proposed fellowship will make her a valuable investigator, with proficiencies
in clinical testing, innovative imaging techniques, and novel computational modeling. Further, this proposal will
facilitate the applicant’s postdoctoral training, laying the foundation for a career as an independent clinical
scientist and strong advocate for diversity in health science fields.

Public health relevance
PROJECT NARRATIVE Adolescents with Achilles tendon injury may suffer long-term health detriments and impediments to physically active lifestyles due to a poor understanding of the health and functional impact of heel pain in patients under 18 years old. This project will investigate the effect of heel pain on adolescent Achilles tendon health and lower limb biomechanics. Findings from this research will provide necessary evidence for establishing the pathoetiology of adolescent heel pain, as proper injury diagnosis will allow adolescents with heel pain to receive the appropriate clinical care and maintain physically active lifestyles into adulthood.